Single-cell and target-specific resolution of multiple memories across the brain

PROJECT SUMMARY / ABSTRACT
A tremendous amount of research has provided us with an understanding of how neurons work in concert
during the formation and retrieval of individual memories. While we understand how memories are stored in a
limited number of brain regions, we do not yet understand how multiple memory traces are stored across
whole-brain neural networks, as well as their real-time physiological dynamics, genetic landscape, and
preferential wiring. What is needed now is technology to bridge the gap in our understanding between
microscopic interactions at the neuronal level and macroscopic structures that perform computations across
networks involved in learning and memory. Using a combination of two activity-dependent tagging systems that
utilize the immediate early genes (IEG) Arc and c-fos, the aim of this proposal is to address the critical need for
obtaining a map of multiple memories and provide the dynamic states of the brain in the context of behavioral
performance and memory expression. We will first utilize behavioral assays and whole-brain imaging to
provide unprecedented insight on how multiple memories (e.g., positive and negative memories) are stored
with single-cell resolution in a brain-wide manner. Identification of similarities and differences between
populations and projections of positive and negative memory ensembles will be quantified and correlated with
behavioral performance by using neuronal modeling developed in the Denny laboratory. Tagged cells will also
be pulled down and sequenced to delineate the genetic landscape differentiating positive and negative
memories. We will then use in vivo Ca2+ imaging to resolve the real-time dynamics (e.g., Ca2+ activity) of neural
ensembles as they participate in positive and negative memory encoding and retrieval. Moreover, we will use
optogenetic modulation to manipulate the positive or negative ensembles in a within-subject manner during
behavioral performance to identify key nodes involved in memory expression. Finally, we will use viral tracing
strategies to determine how these ensembles are structurally wired across brain, thereby providing a wiring
diagram for multiple experiences in the brain. In summary, comprehensive molecular biology,
immunohistochemistry, network modeling, Ca2+ imaging, and optogenetic techniques will be utilized. As most
studies have narrowed their analyses to a single brain structure, these studies will expand this scope
exponentially by analyzing whole-brain memory traces mediating multiple memories. This combinatory system
will result in a whole-brain atlas for individual memories, including positive and negative memories, with single-
cell resolution.

Public health relevance
PROJECT NARRATIVE We propose a combinatorial mouse system for identifying multiple memories with single-cell resolution across the whole brain to better understand how memories are encoded, retrieved, and consolidated. To that end, we will capitalize on genetically engineered mouse models and all-virus based strategies, behavioral assays, whole-brain imaging, in vivo Ca2+ imaging, and viral tracing strategies to indelibly label and manipulate multiple memory traces throughout the brain. This combinatory system will result in a whole-brain atlas for individual memories, including positive and negative memories, with single-cell resolution.